Purifying platelets with high-throughput microfluidics for pediatric and neonatal transfusions

Platelet (PLT) transfusions are necessary to prevent and treat bleeding. However, children and
neonates have worse outcomes with platelet transfusions. Despite being lifesaving, PLT
transfusions may lead to transfusion-related complications, such as transfusion related acute
lung injury, transfusion associated circulatory overload, allergic reactions, and febrile non-
hemolytic transfusion reactions. These complications are largely due to the contaminants that
accumulate in the PLT suspending medium. Common methods of PLT processing include
centrifugation and leukoreduction filters. However, each of these modalities have significant
drawbacks, including premature PLT activation, creation of inflammatory microparticles, and
inefficiency to remove all contaminants (whether large or small). Our objective is to develop and
validate a simple-to-use, disposable device capable of removing all contaminants while
preserving the highest-functioning PLTs. Our novel microfluidic technology, controlled
incremental filtration (CIF), separates blood cells by size using devices with compact footprints
and minimal void volumes, while minimizing cell activation and ensuring practical flow rates. Our
latest CIF device prototypes remove ≥60% of supernatant and recover 98% of large, highly
functional PLT (~90% overall PLT recovery), while minimally increasing PLT activation. The
purpose of this study is to test our hypothesis that purifying PLTs with high-throughput CIF-
based microfluidics is feasible, effective, and safe. We will test this hypothesis through three
Specific Aims. In Aim 1, we will optimize the efficiency of the CIF devices and scale them up to
be able to run at clinically relevant flow rates using human PLT units obtained from a regional
blood blank. In Aim 2 we will evaluate the effect of CIF purification on the hemostatic function of
PLTs in vitro (using a large battery of tests, including flow cytometry, light transmission
aggregometry, and flow adhesion assays (type I collagen, VWF, and thrombin) and in vivo by
transfusing purified human PLT into thrombocytopenic NOD/SCID mice and evaluating
thrombus formation time using photochemical and ferric chloride injury models. In Aim 3, we will
evaluate the safety and efficacy of PLTs purified by CIF in a premature neonatal pig model,
including piglets with necrotizing enterocolitis (NEC). We hypothesize that transfusion of CIF-
processed pig PLT into premature neonatal pigs will be safer (less inflammation) and more
efficacious (less bleeding) than conventional PLT processing methods in piglets with and without
NEC. This project establishes the essential foundation for finalizing the device design and
conducting pivotal human trials, paving the way for safer PLT transfusions in all patients.

Public health relevance
Platelet transfusions are crucial for preventing and treating bleeding, but they have significant side effects, particularly in premature babies. We are developing an innovative device to purify platelets safely and efficiently, maximizing their therapeutic benefits while minimizing potential harm. The purpose of this study is to finalize the design and conduct preclinical testing of our novel device aimed at making platelet transfusions safer and more effective for treating and preventing bleeding in all patients, especially premature babies.